Cortical Complications of Perimenopause and Obstructive Sleep Apnea in Underrepresented Middle-Aged Women with Type 2 Diabetes

Abstract
More than 34 million individuals in the U.S. are living with Type 2 Diabetes (DM). Adult females who belong to
underrepresented racial and ethnic groups are most negatively impacted by risks and complications associated
with DM, including functional impairment in cognitive and sensorimotor actions. Prior work in understanding the
cortical complications in persons with DM (including the development of vascular dementia (VD)) has focused
on independent risk factors such as insufficient sleep and inflammation. DM complications have also been
linked to obstructive sleep apnea (OSA) and sex-hormone changes during the transition to menopause;
however, most studies have included only white non-Hispanic persons. Due to this, we have limited insight into
the multifactorial causes of poor cortical health including DM, sex-hormone influences, inflammation, and OSA
in the most dramatically impacted population living with DM—underrepresented women. In this project, we
seek to fill this critical gap by clarifying how sex-hormones (estrogen and testosterone), inflammation, and OSA
contribute together to the pathogenesis of cortical complications in underrepresented women living with DM.
This proposed project is a logical extension of our recent work that provides mechanistic insight into the
compound contributions of menopause and inflammation to cortical complications and functional impairment in
underrepresented women with DM. Findings from this study will advance understanding of poor cortical health
as a combined function of sex-hormone changes, inflammation, and OSA in underrepresented middle-aged
women with DM. This information pushes forward beyond the knowledge of DM, insufficient sleep,
inflammation, and underrepresented minority status as independent risk factors for VD development. This
project aligns with NHLBI objectives of prevention of heart, lung, blood, and sleep diseases and priorities in in
women’s health, sleep disorders, health disparities, and VD.

Public health relevance
Project Narrative The goal of the proposed project is to identify how sex-hormones, inflammation, and obstructive sleep apnea impact the relationship between brain tissue oxygen use and functional impairment in middle-aged underrepresented women with Type 2 Diabetes (DM). Underrepresented women experience the most severe long-term consequences of DM, including development of vascular dementia; however, we have limited insight into the complex causes of poor brain health in this population. This project will advance understanding of brain health as a combined effect of sex-hormone changes, inflammation, and obstructive sleep apnea in underrepresented women with DM prior to development of vascular dementia.